Recruitment and Engagement Core

RECRUITMENT AND ENGAGEMENT CORE: ABSTRACT
Many American Indian, Alaska Native (AI/AN), and Native Hawaiian and Pacific Islander (NHPI) communities
view academic research with skepticism, mistrust, or even hostility, in part because research has historically
been done in or on communities rather than with community participation. As a result, community-informed
participatory approaches have become the model of choice for research with AI/ANs and NHPIs, because their
core values include equitable distribution of power and resources among partners and mutual respect for the
knowledge that partners offer. In 2013, the National Institute on Aging convened a workshop to articulate goals
for research on Alzheimer’s disease and related dementias as part of the National Plan to Address Alzheimer's
Disease. A priority was the inclusion of disparity populations in research. However, AI/ANs and NHPIs have
been largely neglected by this work, despite striking increases in life expectancy among Native elders. For
example, the 32 current Alzheimer’s Disease Centers have recruited only 110 AI/ANs and 19 NHPIs in the last
7 years (average of 1 person every 2 years per center), despite existing recommendations to increase diversity.
The Recruitment and Engagement Core will apply strategies recommended by the National Institutes on Aging
for recruitment and retention in Alzheimer’s disease and related dementias (ADRD) research,17 with a
commitment to innovative as well as traditional methods to engage communities. These strategies include a
network of 8 Satellite Centers led by AI/AN and NHPI investigators representing a diverse cross-section of
academic and community partners, which will extend the national impact of our work beyond our Research
Projects. These Centers will assess research readiness and through novel “Brain Train” hands-on workshops,
establish an IRB-approved registry of AI/ANs and NHPIs who wish to participate in ADRD research. Our Specific
Aims are to: 1) Monitor and evaluate recruitment and retention in Research Projects by applying innovative
strategies, and identifying best practices for ADRD outreach and engagement; 2) Assess community research
readiness and position AI/AN and NHPI sites for future ADRD studies through a network of Satellite Centers and
“Brain Train” ADRD workshops; 3) Build an IRB-approved research and information registry of AI/ANs and NHPIs
interested in ADRD research; and 4) Create educational and recruitment materials to increase awareness of
ADRD for use by the Research Projects in local communities and national venues. This Core will use strategies
designed to stoke interest in research and treatment advances, both in communities participating in the Research
Projects and in others and ensure stakeholder involvement in biospecimen collection and dissemination of
results. The AI/AN population is growing 3 times faster than the US general population, such that the number of
AI/ANs aged 65+ is expected to triple by 2050, while the number of those aged 85+ will increase 7-fold.19
Corresponding increases are expected for NHPIs. Thus it is imperative to engage the rapidly burgeoning
population of Native elders in ADRD research.